Developmental Research Program

Project Summary
The primary goal of the Developmental Research Program (DRP) of this P20 application is to advance the cancer
health disparities research mission at the Karmanos Cancer Institute (KCI) by developing innovative research
projects that are scientifically sound and translatable. The DRP provides a unique opportunity for soliciting new
research ideas and encourages development of cancer health disparities projects with high translational
potential. These projects provide investigators with the resources to conduct high-impact translational research
consistent with our P20 SPORE's objectives. The goals will be achieved through the following specific aims: 1)
Solicitation of DRP proposals through a highly structured process by leveraging the existing administrative
structure of the KCI; 2) Review applications for new and renewal projects by a DRP Review Committee, which
will recommend up to two new applications and two renewal applications for funding to the Executive Committee
(except for the first year, where two new projects will be supported); 3) Monitor and evaluate funded projects for
progress and translational potential, and assess their potential to become full P50 “SPORE-ready” translational
projects; and 4) Integrate DRP investigators into the SPORE community by requiring participation in monthly
meetings and group communications, and by providing opportunities for expanded collaborations. We will utilize
KCI's existing infrastructure for the DRP to meet the translational objectives of the P20 SPORE and leverage
already established mechanisms to solicit applications. These mechanisms also serve to foster excellent
science in cancer health disparities, recruit new faculty to areas of focus, mentor junior faculty, and encourage
research collaborations. PIs of new and renewal DRP projects will be required to submit written summaries of
research accomplishments to the DRP Committee after 10 months and present these at one of the monthly
meetings of the Executive Committee comprised of the co-leaders of the SPORE projects and core directors.
This meeting will be used to determine whether the DRP projects are sufficiently meritorious for consideration
as full translational projects by the Internal Advisory Board, followed by the EAB and the P20 Cancer Action
Council, as part of a future Detroit Cancer Health Disparities P50 SPORE application. This program will
encourage participation from a broad range of investigators at KCI and Wayne State University by providing
support for pilot projects with the potential to develop into impactful translational projects. It also encourages
and facilitates the development of new research directions, methodologies, and collaborations. Importantly, KCI
has committed to provide the required funds annually for the DRP to fund up to two new projects every year at
a maximum of $50,000 per project per year (with the potential of renewal for up to two projects per year in years
2 and 3).

Public health relevance
Project Narrative Cancer health disparities in incidence, stage at diagnosis, response to treatment, and survival represent a formidable health problem in the United States. To encourage the development of new strategies for reducing cancer health disparities, the DRP will solicit, review, and provide funding for pilot projects involving innovative research aimed at the elimination of race-related disparities.